GROWTH CONTROL IN EPITHELIAL CELLS AND ITS ALTERATION IN CARCINOGENESIS

The mouse epidermal keratinocyte cell line MKDC4, previously established in this project, was further studied for growth in two specially formulated media: (a) LEP/MK2, containing 0.1 mg/ml bovine serum albumin (BSA) and 0.5% bovine pituitary extract (BPE, equivalent to 0.09 mg protein/ml), and (b) LEP/MK4, containing no BPE and 1.5 mg/ml BSA. Growth in the LEP/MK4 medium was found to support colony formation but failed to support extended growth or subculture. The MKDC4 cell line in LEP/MK2 medium was further studied in the presence of inorganic particu- lates. Ferric oxide not only did not decrease colony forming efficiency, but at certain doses induced a stimulation of cell growth and colony formation. Crystalline silica particles of various types, in contrast, induced a marked dosedependent inhibition of these parameters. The MKDC4-derived cell line, 2057C, selected for its ability to grow continuously in the presence of high levels of transforming growth factor beta (1 ng/ml), was reestablished for further mechanism studies. Methods were explored for the establishment of cultures of pulmonary alveolar type II epithelial cells from F344 rats, the target cell for silica-- induced carcinogenesis in vivo.